The Goizueta Alzheimer's Disease Research Center

SUMMARY/ABSTRACT: IMAGING CORE
The Imaging Core of Emory Goizueta Alzheimer’s Disease Research Center (GADRC) supports national and
local Alzheimer’s Disease (AD) and related dementias (ADRD) studies involving imaging and is well positioned
to support the central theme of GADRC towards better understanding of mixed etiology dementia. PET and
MR imaging have greatly contributed to the diagnosis and understanding of AD by enabling in vivo evaluation
of amyloid, tau and neurodegeneration stages. However, there are still unmet needs to fully understand the
heterogeneity of AD both in terms of comorbidities (or mixed etiology) and longitudinal trajectories. The
proposed Imaging Core will advance the goals of GADRC by pursuing four Specific Aims: 1) acquire and
process standard MR and PET image to support national and local research projects; 2) provide an expanding
portfolio of advanced image acquisition and analysis methods to support the study of AD heterogeneity and
mixed-etiology causes to cognitive impairment in AD/ADRD; 3) process and harmonize GADRC-linked imaging
datasets to support precision medicine research and translation to clinics; 4) train the next generation of
researchers and integrate with other GADRC Cores. These Specific Aims are synergistically constructed to
provide standardized imaging, test advanced imaging biomarkers with great potentials to advance AD/ADRD,
enable artificial intelligence research for precision medicine and translation to clinics, and provide an
environment with a wealth of data and imaging expertise for training the next generation of diverse
researchers. Achieving these aims will contribute to advancing the overall goals of the GADRC to unravel the
heterogeneity of dementing diseases.